Cell signaling in development and regeneration

Cell-cell communication plays a central role in embryonic development and adult tissue homeostasis and its
deregulation leads to human diseases including birth defects and cancers. Therefore, understanding how
extracellular signals are transduced and integrated to control cell proliferation and differentiation during
development, tissue homeostasis and regeneration is of central importance in biomedical research. The
overarching goal of this team is to understand how signaling networks control organ development and
regeneration, with an emphasis on Hedgehog (Hh), Hippo, and BMP signaling pathways. Hh signaling
controls many key developmental processes in species ranging from Drosophila to human and its abnormal
activity has been implicated in numerous human cancers including medulloblastoma and basal cell
carcinoma. Hh acts through a conserved signaling cascade emanating from the GPCR family receptor
Smoothened (Smo) to the Zn-finger transcription factor Ci/Gli but how Smo activates Ci/Gli is still poorly
understood. In this proposal, the team will combine genetics, biochemistry, cell biology, and biophysical
approaches to explore conserved mechanisms governing Smo trafficking, phosphorylation-dependent and -
independent activation of Ci/Gli, and the molecular links between Smo and Ci/Gli. The Hippo pathway was
initially discovered in Drosophila and plays a conserved role in the control of tissue growth and organ size by
simultaneously regulating cell proliferation and survival. Deregulation of Hippo signaling has also been
implicated in many types of human cancer. Despite its central importance in development and diseases, the
mechanisms underlying Hippo pathway regulation under physiological conditions or deregulation under
pathological conditions remain incompletely understood. The team has developed a genetic modifier screen
allowing them to identify novel and evolutionarily conserved Hippo pathway regulators. The team will continue
to investigate the mechanisms by which the newly identified components regulate Hippo pathway activity in
organ size control and tissue regeneration. The team has pioneered the use of Drosophila adult intestine as
a model system to investigate how stem cell self-renewal, proliferation, and differentiation are regulated
during tissue homeostasis and regeneration, and identified Hippo, Hh and BMP signaling as essential for the
regulation of stem cell activity. In the previous funding period, the team has also established Drosophila adult
intestine as a model to study in vivo reprogramming after injury and began to explore the molecular
underpinning. In the proposed study, the team will investigate how other cell extrinsic and intrinsic factors
acts in conjunction with BMP signaling to promote stem cell self-renewal and explore the genetic and cellular
mechanisms that control the reprogramming of fully differentiated cells to adult stem cells in response to
injury. The knowledge gained from this study will have important implications for developmental biology,
cancer biology, and regenerative medicine.

Public health relevance
Conserved cell signaling pathways such Hedgehog and Hippo pathways play essential roles in embryonic development and adult tissue homeostasis in species ranging from Drosophila to human. Deregulation of Hedgehog and Hippo pathway activities has been implicated in many types of human cancer. Understanding how Hedgehog and Hippo pathways are regulated and how these and other signaling pathways are integrated to control embryonic development and adult tissue homeostasis should not only provide novel insights into the etiology of human disease but may also provide new avenues for therapeutic treatment of cancer.